Advancing Treatment for Head and Neck Cancer Patients with Competing Health Risks through Multi-Center Randomized Trials

PROJECT SUMMARY ABSTRACT
Head and neck cancer is a major cause of morbidity and mortality worldwide. My clinical research program
focuses on novel alternative therapeutic strategies for head and neck cancer patients who are medically unfit
for standard treatment, which differentially affects older populations with comorbidities and medically
underserved populations. Historically, these patients have been poorly represented in clinical trials. I have
dedicated my career to advancing care of head and neck cancer patients through clinical research, and have
served as national PI, national co-chair, and co-author for multiple NCTN trials, as well as contact PI for NRG
Oncology at UCSD. I have also led multiple funded IITs, previously holding numerous NIH grants including
KL2, R21, and R01 grants supporting my clinical trials work. Recently, our field has seen a consistent string of
failures of experimental arms in high-profile trials, highlighting the need for continued work to define the
standard of care and develop new therapeutic strategies through NCI-sponsored trials. This project will
advance science in this arena through my activities as a national leader in NRG Oncology and as Co-Chair of
the NCI Head and Neck Steering Committee (HNSC), including the active development of the NRG HN2437
Phase II Randomized Trial concept. In addition, through my roles as NRG Contact PI and MCC Head and
Neck Disease Team Co-Leader at my institution, I will continue to support accrual to NCI-sponsored trials, and
as a scientific collaborator and co-investigator, will actively support accrual to NCI-sponsored institutional IITs
that are advancing novel treatment paradigms. This grant will additionally enable me to fulfill my ambition of
proposing a Clinical Trials Planning Meeting addressing older patient populations and engage in mentorship of
emerging investigators. Lastly, it will enable me to continue implementing novel risk-assessment methods that I
have developed, using competing event models to define subpopulations who selectively benefit from intensive
treatment. For over 16 years, I have served as a research leader at UCSD's Moores Cancer Center (MCC),
where I have been Head and Neck and Radiation Disease Team Leader and have led its NRG program since
2008 from affiliate to full voting member status. MCC is the only NCI-designated Comprehensive Cancer
Center serving San Diego and Imperial Counties in Southern California. Its clinical trials program is the
principal locus of clinical cancer research in the region, which serves a large, ethnically diverse population, with
a high prevalence of underrepresented minorities and non-English speaking patients. This grant will also
enable me to support innovative collaborations at UCSD, resulting in novel therapeutic strategies. Ultimately,
this project will promote novel clinical trials that will improve outcomes for head and neck cancer patients with
contraindications to standard therapy, defining new standards of care for future generations.

Public health relevance
NARRATIVE This proposal describes my long-standing qualifications and contributions for over 16 years supporting NCI- funded clinical trials, both through my leadership at UCSD's NCI-designated Moores Cancer, where I have been a Disease Team Leader and have led its NRG program as Contact PI since 2008, and nationally within NRG Oncology and the NCI Head and Neck Steering Committee (HNSC). I have served as national PI, national co-chair, and co-author for multiple NCTN trials, have led multiple funded IITs, and have previously held numerous NIH grants including KL2, R21, and R01 grants supporting NCI-sponsored clinical trials work. This grant will support my clinical research program, which focuses on novel alternative therapeutic strategies for head and neck cancer patients who are medically unfit for standard treatment, a discipline that differentially affects older populations with comorbidities, who have been historically underrepresented on clinical trials.